NMR Research Core Facility

The NMR Research Core Facility consulted on many projects in FY2021. The following investigators utilized the facilities.
Paul Doetsch: The NMR core provided metabolomic analyses of E. coli extracts, and examined unfolded proteins.
Traci Hall: RNA binding proteins were characterized.
Jason Watts: The NMR core examined nucleotide samples for evidence of G quadruplex formation.
Gaylia Jean Harry: Metabolomic samples of mouse brain extracts were characterized.
Suchitra Kaveri Hourigan: Fecal samples from leukemia survivors were characterized.
Suramya Waidyanatha: PFAS concentrations were measured.
Brian Walitt: Serum and cerebrospinal samples from patients with chronic fatigue syndrome were characterized for metabolites present.
Paul Wade: NMR samples of histone proteins were prepared with and without stable isotopes.
Robin Stanley: 19F NMR was performed for sample characterization.
Anant Parekh: Drug binding was measured. Peptide structures were characterized.
Jerry Yakel: Peptide affinity for protein targets was measured.
Carlos Guardia: Protein samples were characterized.